Steroid Hormone Regulation of Brain Plasticity and Vocal Behavior

Project Summary
Basic and clinical research that was initiated in the late 20th century and continues to this day has transformed
our thinking about brain resilience. The term brain plasticity is often invoked to describe adaptive changes in the
adult brain. This proposed research program concerns the study of neuroplasticity in a seasonal context. This
phenomenon involves naturally occurring brain changes that allow an animal to cope with seasonal variation in
the physical and social environment to facilitate survival and reproductive success. We study how the steroid
hormone testosterone regulates brain changes and the associated changes in behavior in seasonally breeding
male and female canaries. These birds possess a well-defined neural circuit, called the song system, which
regulates an important learned social behavior, song. Song varies seasonally in that it is more common and
more complex in spring when it is produced primarily by males to attract females. Females also produce song
but at a lower rate with simpler structure. Key forebrain song nuclei are much larger in volume in the spring in
males than in the fall when song is produced less frequently; these song nuclei volumes also are larger in males
than in females. Such seasonal changes in brain and behavior may recapitulate behavioral and brain plasticity
that occurs during the vocal learning process. Our recent work in canaries has shown that testosterone acts in
a pleiotropic manner to regulate multiple aspects of song behavior by having anatomically specific effects in the
forebrain song nuclei and in the medial preoptic area, that testosterone can induce male-like changes in
neurogenesis and in song behavior in adult female canaries but apparently cannot induce a complete sex
reversal, and finally that species variation in perineuronal nets (specialized structures of the extracellular matrix)
correlates with species variation in adult vocal plasticity. In this proposal, we capitalize on these findings by
investigating the regulation by steroid hormones of brain plasticity and the related song learning and behavior
as well as sex differences in their action. The proposal is organized into four aims. In Aim I we ask whether
steroid hormone-induced plasticity in the song control nucleus is similar in males and females. Aim II investigates
indirect effects of testosterone on song behavior and brain activity related to song by assessing how steroid
action in the medial preoptic nucleus indirectly facilitates song-related immediate early gene expression and
singing behavior in the song control circuit. Aim III addresses the critical question of the function of adult
neurogenesis in songbirds as we will ablate neuroblasts in a site-specific manner with the use of the focused X-
ray irradiation method in the ventricular zone in testosterone-treated male and female canaries and assess the
morphological and behavioral consequences of these ablations. In Aim IV we will test the hypothesis that
perineuronal nets play an important role in limiting brain and behavioral plasticity as it applies to song learning.
This research will contribute to the development of more mechanistic insights into brain plasticity as well as help
us identify how steroid hormones might serve in a neuroprotective and/or cognitive enhancer-like manner.

Public health relevance
Project Narrative Understanding how the brain can renew itself in adulthood and the functional consequences of such a renewal is a major goal of modern neuroscience, NINDS and this research program. Experiments described in this proposal will enhance our knowledge of brain renewal in that they focus on naturally occurring seasonal cycles of brain renewal that are regulated by steroid hormones to identify where and how steroids can act in the brain to change brain morphology and behavior. We will study comparatively in males and females how hormones that regulate a brain circuit via both direct and indirect actions will modify adult brain neurogenesis and local connectivity and the consequences of these brain changes on the learning and motivation of vocalizations involved in social communication.